B - Data Management, Acquisition, and Resource Sharing

PROJECT SUMMARY/ABSTRACT
Core B – Data Management, Acquisition, and Resource Sharing
The nexus of research proposed in this program project draws on a wide and complex array of data sources.
The goal of the data core is to build, manage securely, and facilitate access to a myriad of both traditional and
innovative data resources that enable cutting-edge scientific research on health and aging. With the increasing
use of complex and restricted-access databases, administrative records from government agencies, data from
health care providers and insurers, employer data, linked data, and new data collections, it is imperative that
our data are managed professionally. Issues of data security, adherence to data use protocols, and protection
of confidentiality in the data are critical aspects of the research environment in which we work. Beyond routine
data management responsibilities, the core has the goal of creating a rich data infrastructure for health-related
research that takes full advantage of new data opportunities in the evolving landscape of health, health care,
and health policy. The data core will serve the research investigators and activities that comprise the program
project grant, but it also anchors the data support systems for the NBER's health and aging programs more
broadly. A number of specialized tasks are planned for the continuation grant. First, the core will continue to
maintain, update, enhance, and promote the use of a Medicare claims database with health and health care
information for over 100 million Medicare beneficiaries over the past 30 years. Second, the core will develop as
a research resource medical claims data covering populations beyond our Medicare data, taking advantage of
the diversity of health plan provisions, state-specific programs, accountable care organizations, Medicaid
policies, and other policy and payment variations system-wide. Third, the core will enhance as a research
resource the SEER cancer registry data, including the construction of more sophisticated analytic variables on
patient diagnoses. Fourth, the core will compile and manage new analytic resources based on hospital and
other provider records. The core will also continue in its role of facilitating researcher access to data resources,
overseeing and enforcing all data security and restricted use protocols associated with sensitive and
proprietary data, and seeking out and developing new data resources useful for health and aging research.

Public health relevance
PROJECT NARRATIVE – PUBLIC HEALTH RELEVANCE The goal of the program project is to better understand health trends and disparities, the determinants of health, and approaches to improving health in an evolving landscape. The data core supports this effort by developing, maintaining, and facilitating access to a rich data infrastructure that enables cutting-edge scientific research on improving the health of an aging population.